Role of neurokinin 1 receptor signaling in keratinocytes in allergic contact dermatitis

ABSTRACT
Allergic contact dermatitis (ACD) is a highly common chronic inflammatory skin disease initiated by skin exposure
to a hapten, which triggers local neuroinflammatory responses and promotes the activation of pathogenic Type
1 biased effector T cells that sustain the chronicity of the disease. There is an unmet need for specific
immunotherapies to treat ACD, and development of these treatments requires a thorough understanding of the
cellular and molecular mechanisms of the disease.
During hapten penetration of the skin, signaling the neurokinin-1 receptor (NK1R) by the proinflammatory
neuropeptides substance P and hemokinin-1 promotes cutaneous inflammation. This proinflammatory skin
environment is required for the T cell-stimulatory and Type 1 biasing function of resident dendritic cells (DCs).
Because lacking NK1R in mice impairs the development of ACD it has been proposed that blockade of the
receptor could be beneficial to treat the disease. Understanding the impact of NK1R-signaling in the immune
response to haptens is of fundamental relevance for therapies attempting to inhibit the function of the receptor
to treat ACD. Nonetheless, the cellular and molecular mechanisms and the pathogenic consequences of hapten-
mediated NK1R activation in the skin remain to be elucidated.
Keratinocytes constitute the first line of defense affected by contact sensitizers and they have per se a
relevant role in innate and adaptive components of skin-initiated immune responses. Keratinocytes are the main
cell subset that expresses constitutively the NK1R. Using NK1Rfl/fl mice, we published that specific deletion of
the NK1R in keratinocytes impairs the synthesis and secretion of IL-1β, a cytokine necessary for the activation
of T-cell stimulatory DCs, and inhibits the innate and adaptive immune responses of ACD. Therefore, we
hypothesize that: “Keratinocytes are early cell targets of hapten-mediated NK1R-signaling, and that they
are required to generate the proinflammatory skin environment that supports the innate and effector
immune responses of ACD”. We will address this hypothesis in the following specific aims. Specific aim 1 will
analyze the mechanisms of the proinflammatory effects caused by NK1R-signaling in keratinocytes exposed to
haptens. Specific aim 2 will analyze the mechanisms of intercellular communication by which keratinocytes
interact with skin resident DCs to promote their T cell stimulatory functions during hapten initiated skin
inflammation. Specific aim 3 will analyze the role of the NK1R-signaling exclusively in keratinocytes in the
generation of the effector and memory T cells of ACD. Our studies include in vitro and in-vivo mouse models
and ex-vivo human skin models to test the translational relevance of our experiments. If successful, the data
generated through this application will provide highly relevant missing information for the development of efficient
specific therapies for the prevention and treatment of ACD.

Public health relevance
PUBLIC HEALTH RELEVANCE Allergic contact dermatitis (ACD) is a substantial health problem that with a prevalence of 18% is the second highest cause of work-related diseases in the USA. There is an unmet need for more specific immunotherapies to treat ACD, which is caused by intricate interactions among neuro-mediators, skin resident cells, and migratory leukocytes. The present application proposes to investigate relevant mechanisms of these cellular and neuroimmune networks to provide fundamental physiopathologic insight for the development of specific immunotherapies for ACD.